Vaping has an immunosuppressive effect, rendering the lung more susceptible to microbial infections

Project Summary/Abstract
Respiratory disease carries a significant worldwide burden of morbidity and mortality. Currently it is well
understood that tobacco smoking is a major cause of pulmonary/lung inflammation, which can progress onto
pulmonary disease. However, significantly less is known about the effects of e-cigarettes (E-cigs) on the lung.
Our study will assess whether vaped e-liquid (the actual product consumed/”vaped” by the E-cig user) exposure
renders the lung more susceptible to pulmonary distress/disease using an ex vivo human bronchial epithelial
cells (HBEC) model followed by our developed in vivo (C57BL/6J) lung injury model. We will also investigate the
immune cell populations involved in any resultant lung injury.
Hence, the goals of the current proposal are to model lung cell immune dysfunction using HBEC (Aim
1). To assess immune cell involvement/recruitment and lung pathology post-vape exposure using our in vivo
model (Aim 2). We will then determine whether pre-exposure to e-liquid aerosol renders C57BL/6J mice more
susceptible to pulmonary distress/disease using Klebsiella pneumoniae as a pathogen challenge model (Aim
3). Completion of the proposed Aims will ultimately shed light on the possible health implications of new and
emerging tobacco products (such as E-cigs) and provide mechanistic detail on the possible initiation and
progression of lung disease in E-cig users.

Public health relevance
PROJECT NARRATIVE Although the deleterious effects of traditional cigarette smoking have been documented widely, significantly less is known about the health effects and safety profiles of new (introduced widely only within the past 15 yrs) and emerging tobacco products, i.e., E-cigarettes, on the lung. This proposal seeks to expand upon our understanding of the use and effect(s) of new and emerging tobacco products. Through these studies, we will (1) mechanistically investigate the pulmonary consequences of E-cigarette use, or vaping, and (2) whether vaping renders the lung more susceptible to pulmonary disease initiation and progression due to microbial challenge.